Community Engagement and Outreach

Project Summary / Abstract
The overall objective of the Community Engagement and Outreach (CEO) Core is to support investigators across
the 13 Clinical Translational Research Infrastructure Network (CTR-IN) partner universities located throughout
the Mountain West (MW) to focus our clinical and translational research activities on vulnerable populations
experiencing health disparities. Our large urban populations separated by large areas inhabited by small rural
communities both share one significant common characteristic: the existence of health disparities throughout
both urban and rural residents of the MW region. Addressing health disparities in these regions can be
challenging, as each community can have unique characteristics that must be considered when engaging in
research designed to achieve health equity.
We will accomplish our overall objective through the following 3 Specific Aims that will facilitate a community
engagement approach to addressing the critical problem of health disparities across the MW Institutional
Develop Award (IDeA) states. Through Aim 1, we will develop and implement the CEO Core, providing mentoring
and training opportunities for CTR-IN researchers that conduct community-engaged research related to health
disparities. In Aim 2, we will engage health care professionals, community members, and researchers through
the development and implementation of regional and CEO Core Community Advisory Boards (CABs). These
CABs will assist identifying and prioritizing health disparities within our regional populations for our CTR activities.
Finally, Aim 3 will integrate community engagement throughout the CTR-IN Cores and network, implementing
an overall philosophy of working with communities to improve health disparities throughout the MW IDeA state
region. Community engagement is critical in health disparities research. An experienced CEO Core Director and
Site Directors at each of the 13 institutions will serve as a vital informational network as they support investigators
throughout the 7 states in their health disparities research studies, from concept through results dissemination.